Computational roles of inhibition in human action control

Abstract
Classic neurocognitive models of cortico-basal ganglia circuits imply excitatory signals drive, and inhibitory
signals suppress, behavioral output. However, inhibition can support other computations. Research on animal
motor systems and human sensory systems has shown inhibition shapes the gain and tuning properties of neural
populations. The overall objectives of this application are to establish roles for gain modulation and tuning within
the human motor system during action preparation and to evaluate to what extent these computations relate to
the neurochemical capacity for inhibition. Accordingly, the proposed experiments will test the central hypothesis
that gain and tuning within the human corticospinal pathway change dynamically during the preparation of
actions and relate to inhibitory neurotransmitter availability in motor cortex. The first specific aim of this
application is to test the hypothesis gain within the human motor system increases during action preparation to
facilitate the execution of a selected action. The second specific aim is to test the hypothesis spatial tuning of
motor representations sharpens during action preparation. Whereas Aim 1 examines a computational
mechanism for facilitating the execution of a selected action, Aim 2 examines a computational mechanism for
selecting actions from a pool of neighboring and overlapping representations. We will use non-invasive brain
stimulation to examine the patterns of excitability within a given muscle (Aim 1) and across a group of muscles
(Aim 2) to detect changes in gain and tuning, respectively, during behavioral task performance. The third specific
aim of this application is to explore relationships between gain, tuning, and local availability of the inhibitory
neurotransmitter gamma-amino butyric acid (GABA) in the cortex. Individual differences will be examined to test
whether the availability of local GABA correlates with the magnitude of gain and tuning changes. We hypothesize
individuals with more GABA in motor cortex will exhibit greater increases in gain and sharper tuning during action
preparation. The proposed work is innovative because the roles of gain and tuning within the human motor
system are crucially understudied and their links to neurochemical content are completely unexplored. This
research is significant because the results could change our interpretation of the roles of inhibition in behavioral
control. Abnormalities in inhibitory mechanisms are associated with symptoms of Parkinson’s disease, stroke,
and dystonia, and knowledge gained from the proposed experiments can help identify new targets for therapeutic
interventions.
In this diversity supplement, we request funding for Ms. Hayami Nishio, a graduate student in the Action Control
Laboratory (PI Greenhouse), to model the electric fields produced by the non-invasive brain stimulation
technique proposed in Aim 2. This novel addition will separate anatomical properties from neurochemical
properties that can influence motor system tuning measurements. Ms. Nishio will receive training in motor
physiology, navigated brain stimulation, computational methods, and career development.

Public health relevance
Project Narrative The proposed work will contribute to our knowledge about the neural, cognitive, and computational mechanisms involved in human action control. This research will help determine which specific mechanisms are impacted in motor disorders and help identify new targets for therapy. Isolating specific mechanisms will improve our ability to treat and potentially cure disorders such as Parkinson’s disease, dystonia, and stroke.